Health effects of cannabidiol vaping products

PROJECT SUMMARY
Increasingly, consumers are vaping cannabinoids such as cannabidiol (CBD) or CBD-derived
tetrahydrocannabinols (THCs), such as Delta-8-tetrahydrocannabinol (∆8-THC) and other THC isomers. Like in
nicotine-containing e-liquids, flavoring chemicals are intentionally added to THC vaping liquids to make them
more appealing for customers. In addition, metals, terpenes, pesticides, and microbial products have also been
identified in commercially available THC vaping liquids. Chemical stability studies indicate that THCs can readily
oxidize. Specifically, CBD and Δ8-THC have been shown to oxidize to their reactive quinone (CBDq and Δ8-
THCq). Contaminant metals, such as Cu and Fe, catalyze the oxidation to Δ8-THCq. Similarly, flavoring
chemicals like furanone compounds, providing a fruity flavor, have been shown to be pro-oxidants. However, the
extent to which vaping liquid constituents, like metals and flavoring chemicals, oxidize THC isomers to reactive
electrophilic quinones or other oxidation products and whether they pose a significant risk for lung health is
completely unknown. Quinones, such as CBDq and Δ8-THCq, are Michael acceptors capable of covalently
modifying biological molecules, especially proteins containing thiol groups. We hypothesize that 1) constituents
like flavoring chemicals and metals, increase vaping-induced oxidation of THC and 2) the resulting quinone
oxidation products cause airway epithelial cell toxicities through protein modification. Aim 1 will identify vaping-
induced oxidation products and determine how vaping liquid constituents (metals, flavoring chemicals) affect the
oxidation of THC isomers. Aim 2 will use our newly developed in vitro Vaping Product Exposure System (VaPES)
to expose differentiated human bronchial epithelial cells (HBECs) to 1) commercial liquids, 2) lab-made liquids
containing specific constituents, or 3) specific oxidation products. Aim 2 will link pro-oxidant constituents with
protein adduction to cellular thiol groups and biological responses. Alkyne-tagged CBD and Δ8-THC analogues
have been prepared for use in “click” cycloaddition to identify protein adduction of inhaled oxidant. In addition to
specific targets, major proteins in the overall “adductome” will be identified, this uncovering novel cellular targets
and biological pathways affected by inhalation of THC oxidation products. Aim 3 will collect nasal mucosal
samples from non-vapers and frequent THC vapers and examined for a) tissue-level gene expression, b)
untargeted metabolomic and proteomic profiles, and c) chemical biomarkers of exposure. Integrate multi-omic
computational data analysis will be applied to uncover dysregulated immune pathways in the nasal mucosa of
THC vapers. Data obtained from this grant will identify constituents of commercial THC vaping products
impacting oxidation, toxicity, and normal functions of the airway mucosa in vitro and in vivo. To better understand
the interaction between vaping-induced oxidation of THC products, signaling cascade initiation, and respiratory
mucosal immune signaling, the translational and integrated multi-omic analysis proposed here, is critical for
advancing the safety of THC vaping products.

Public health relevance
PROJECT NARRATIVE Cannabidiol (CBD)-derived tetrahydrocannabinol (THC) products, such as Delta-8-THC (∆8-THC) are legal and increasingly used in vaping devices. Vaping-induced oxidation of CBD, ∆8-THC, and other THC isomers is likely enhanced by pro-oxidant constituents in the liquids, such as metals and flavoring chemicals. Studies outlined in this application will link pro-oxidant constituents in THC vaping liquids and vaping-induced oxidation products, with modified biological functions in epithelial cells using in vitro and in vivo models, thus providing novel, urgently needed, mechanistic information on vaping THC products.